CAPACITY BUILDING FOR HEALTH PROFESSION EDUCATION AND RESEARCH IN MALAWI (CHEER-MALAWI)

CAPACITY BUILDING FOR HEALTH PROFESSION EDUCATION AND RESEARCH IN MALAWI (CHEER-
Malawi)
PROJECT SUMMARY:
Malawi faces the double encumbrance of high burden of communicable diseases and an increasing burden of
non-communicable diseases. From the latest Global Burden of Disease Report (2013), HIV and AIDS (34.9%)
and other communicable conditions such as malaria, diarrheal diseases and respiratory infections combined
(23.2%) are the major contributors to Disability Adjusted Life Years (DALYS)[1].
Under the Health Sector Strategic Plan I 2011-2016, Malawi made substantial health gains by reducing infant
mortality, Under-5 mortality, maternal mortality ratio (MMR) and HIV prevalence among women and men age
15-49 years[2]. Despite the progress, Malawi's MMR and neonatal mortality rate (NMR) are among the highest
in Sub-Saharan Africa. Educational programs at COM and KCN have in part contributed to the strengthening of
the health system through the production of pre-service as well as the training of post-basic health
professionals and conduct of relevant health research.
Despite the increase in the numbers of health professionals produced by both COM and KCN, significant gaps
remaingiven theMalawian population is rapidly increasing in size. The challenge in further increasing the output
from educational institutions, while maintaining and improving the quality of its graduates, call for innovative
ways of pedagogy and research. This can be achieved by improving the quality of Health Profession Education
(HPE) through establishment of a center of excellence in HPE; strengthening research capacity and
governance; encouraging inter-professional education and training; and decentralizing education and training
to the community setting including rural and peripheral sites. This has potential to increase access to health
education thus ensuring continuing professional development of health care workers. This will be done through
long-term and sustainable coordination between educational, community and research institutions in a
collaborative manner to address the health needs of the nation.
This grant application brings together a consortium of key institutions and individuals that are currently
championing health profession education and research in Malawi. The consortium is purposefully designed to
build capacity within COM, the only public higher education institution offering training in medicine and degree
level allied health programs such as physiotherapy, pharmacy and medical laboratory science; KCN, the only
higher education institution offering nursing degree programs at undergraduate and postgraduate levels;
Malawi College of Health Sciences (MCHS), the major training institutions for diploma level allied health
workers and nurses; and the Malawi Ministry of Health and Population (MOH), the major provider of health
services, to ensure maximal buy-in at national policy level and sustainability as well as strengthening inter-
professional collaboration in education, research and service delivery.
1

Public health relevance
CAPACITY BUILDING FOR HEALTH PROFESSION EDUCATION AND RESEARCH IN MALAWI (CHEER- Malawi) PROJECT NARRATIVE: This project aims to improve the quality of health profession educators; strengthen the research capacity of health professionals and health education institutions in Malawi; foster inter-professional education and research among healthcare workers through community-based district learning platforms in order to meet the challenges posed by the double burden of communicable and non-communicable diseases including HIV. These goals will be achieved by establishing a Health Profession Education (HPE) Center at College of Medicine (COM) while also strengthening the existing NEPI-supported Nursing and Midwifery education programs at Kamuzu College of Nursing (KCN) leading to improvements of pedagogical skills of health profession educators nationwide. Integrated multidisciplinary and inter-professional education and research collaboration among health professions will be strengthened at the community level to facilitate implementation of local research findings. We will strengthen research capacity and governance at COM and KCN by utilizing existing resources at COM and its international research affiliates to initiate formal research governance and grants management at KCN; expand the COM Research Ethics Committee through recruitment and training of more IRB members to encompass the growing needs at COM and KCN; and modernize grants management systems at COM Research Support Centre (RSC) to improve efficiencies in processing of proposals. 1